University of Miami IBD Genetic Research Center: Understanding the Genetic Architecture of IBD in the LatinX Community

PROJECT SUMMARY
Inflammatory bowel disease (IBD) is a common and devastating immune-mediated disease in which the
mucosal immune system abnormally recognizes the intestinal bacterial flora leading to chronic inflammation.
Approximately, 1% of the US population is affected. The causes of Crohn's disease (CD) and ulcerative colitis
(UC) lie in the interplay between host response genes and a microbiome with pathogenic properties. IBD
incidence has leveled off in the developed world and rising in the newly industrialized world. In the US, we are
witnessing a rising incidence in immigrants from low-risk parts of the world, particularly Hispanics. This provides
an opportunity for discovery of disease pathogenesis towards a goal of prevention and improved therapies.
Unfortunately, most genetic studies of IBD, including from the IBDGC, have focused on individuals of European
ancestry from North America and Europe. Moreover, most clinical trials of IBD medications include too few
Hispanics or Blacks and thus do not represent the totality of the affected population.
Our group has a dedicated research interest on IBD in Latin-American immigrants and American-born
Hispanic patients. We have published highly-cited studies of the genotype and phenotype of IBD in the Hispanic
population of South Florida. We have also described disparities in medication usage and surgical rates. Important
for the notion that IBD is caused by a gene-environment interaction, we have found that IBD is occurring faster
in the last 20 years in immigrants from Latin-America. We have been very successful in our collection efforts
because of our location and our commitment and engagement in the Hispanic community. We have a unique
opportunity and obligation to study this disease within the Hispanic population. Miami-Dade County is over 50%
Hispanic. The state of Florida has the 3rd largest Hispanic population and the most diverse in terms of countries
of origin. We are poised with the support of an IBDGC grant to expand our collection efforts to the broader state
of Florida. Genome-wide association studies (GWAS) have facilitated the discovery of previously unrecognized
genes and pathways in IBD and provided the opportunity for unbiased exploration of the genomes of patients
with IBD. We will explore genetic variation in a large set of US-born and foreign-born Hispanic IBD cases by
focusing on targeted genomic, transcriptomic, and epigenetic differences between immigrant and first-generation
Hispanic-Americans with IBD. We will edify how genes and environment interact to result in diverse phenotypic
manifestations of IBD. Our group has particular expertise and interest in methods to fine-map previously
identified risk loci and access the impact of local genetic ancestry on genotype-ancestry interactions in relation
to phenotypic characteristics, with the goal of identifying genetic variation of functional significance. Our
proposed studies will expand knowledge of disease phenotype and genetic underpinnings in IBD in this growing
Hispanic cohort in the hopes of developing prevention and improved treatment approaches.
We will use the complementary strengths of the two PIs to catapult discoveries and meet the goals of the
NIDDK IBD Genetics Consortium (IBDGC) to expand the collection of Hispanic IBD patients in the US.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel diseases (IBD) are immune-mediated diseases whose downstream consequences include surgery and cancer, leading to medical disability and a high economic and social burden in the US. Although traditionally thought of as a disease affecting Caucasians of European descent, a rising number of Hispanics, both foreign-born and first-generation Hispanic-Americans, are developing IBD. In this proposal, we will dramatically increase the breadth of the Hispanic genetic sample collection in the US paired with careful phenotyping to make discoveries on the pathogenesis of IBD through novel, high-resolution genetic and genomic approaches.